Expanding the pool of Independent Investigators in Implementation Science in Nigeria throug h HIV research training (EXPAND)

PROJECT SUMMARY
Women and girls constituted 53% of all people living with HIV, and nearly 2/3 of all new HIV infections in Africa
were among women and girls in 2022. Prevalence of intimate partner violence (IPV) among the general
population of women aged 15 to 49 years in the WHO African region is ~33%, and as high as 63% for those
who are living with HIV. Women and Girls Living with HIV (WGLHIV) experience significant risk for new-onset
IPV or its intensification when they disclose their HIV status to their male partners. Besides HIV, the risk of IPV
is higher for women if they are pregnant, sex workers, or adolescent girls and young women (AGYW) and we
have chosen to focus on these vulnerable, hardly reached WLGHIV in Northern Nigeria (Sokoto, Northwest
Zone and Abuja, North Central Zone) for this study. There is less IPV evidence in Northern Nigeria as
compared to the South; this allows us to better understand and inform IPV service delivery in the Northern
socio-cultural context.
Our SWANN study is a cross-sectional, mixed methods study which will inform changes in IPV tools and services;
we aim to further center survivors and then adopt a survivor-provider co-creation approach to revising IPV tools.
These tools, which inform the “what” and “how” GBV/IPV services are delivered, were developed by multilateral
and bilateral organizations as well as local NGOs, however, to date, there has not been input or evaluation by
GBV/IPV survivors. To increase the evidence base and survivor-centeredness of IPV services for WGLHIV in
Nigeria, our approach will be informed as follows:
Aim 1: To assess the prevalence of all types of IPV among vulnerable women and girls living with HIV in
North-Central and North-West Nigeria.
Aim 2: To explore the range of IPV and IPV service experiences among vulnerable women and girls living with
HIV in North-Central and North-West Nigeria
Aim 3: To increase survivor-centeredness of existing tools for intimate partner violence services in HIV
programs in Nigeria
The proposed study is designed to center and address the needs of women and girls living with HIV who are
highly vulnerable to IPV in Nigeria’s HIV program. The structured review of GBV/IPV tools is expected to
strengthen, and better integrate structured IPV services for WGLHIV in HIV programming. Our established
partnerships with legal, women’s and state agencies, organizations and advocacy groups will help ensure
applicability to local legal and policy context, influencing state and federal policy to better protect women at risk.

Public health relevance
PROJECT NARRATIVE Achieving HIV epidemic control includes actions to educate and mitigate against structural vulnerabilities such as male violence against women and girls especially intimate partner violence (IPV). We propose a survivor- provider co-creation approach to engage Women and Girls Living with HIV who are survivors of IPV to co-review and co-revise existing tools with IPV providers to effect context-specific, survivor-centered changes to improve IPV service appropriateness and impact.